Cardiometabolic Diseases: The Role of Ethnic Diversity in Precision Medicine

ABSTRACT
Support is requested for a Keystone Symposia conference entitled Cardiometabolic Diseases: The Role of Ethnic
Diversity in Precision Medicine, organized by Drs. Paul Franks, Ewan Pearson and Karin Conde-Knape. The
conference will be held in Vancouver, British Columbia, Canada from February 4–7, 2024.
Cardiometabolic disease constitutes a major threat to global health, with the greatest affliction occurring outside
the western world. Precision medicine has enormous potential to reduce this burden yet the data that will seed
precision medicine algorithms and products often stems from people of European ancestry living in high-income
societies. Addressing this bias is important because a failure to do so may drive significant health inequities,
rather than diminish them, as precision medicine has the potential to do. Best viewed as an evolution rather than
a revolution, precision medicine will not replace, but may substantially enhance, contemporary medicine. Its key
pillars are diagnostics, prediction and prevention of the primary disease, prognosis of secondary disease,
treatment, and monitoring of risk exposure, treatment response and disease progression. For precision medicine
to fulfil its potential, a well-functioning ecosystem will be necessary, comprised of multiple stakeholders,
furnished with powerful computing infrastructures, and fueled by multidimensional data generated in people of
diverse ethnicities living in varied environments. This conference will be paired with another Keystone Symposia
conference entitled Obesity: Causes and Consequences. The joint conferences will share a keynote and joint
sessions. Participants of both conferences will also have an opportunity to network at shared mealtimes and
poster sessions. It is anticipated that this will lead to new scientific collaborations and the implementation of new
precision medicine approaches directed at better understanding and treating cardiometabolic disease.

Public health relevance
PROJECT NARRATIVE Cardiometabolic diseases, such as cardiovascular disease, diabetes, obesity, and fatty liver disease, are considered the leading preventable causes of death in most geographies around the world. However, the origin, clinical presentation, and pathogenesis of these cardiometabolic diseases greatly varies worldwide, as do the resources and strategies needed to prevent and treat them. This Keystone Symposia conference will bring together scientists from all over the globe to discuss the latest in precision medicine, develop new scientific collaborations and discuss ways to implement precision medicine approaches to better understand and treat cardiometabolic disease.